2/2-Dopaminergic Dysfunction in Late-Life Depression (The D3 Study)

PROJECT SUMMARY: Growing evidence suggests that dopamine contributes to key functions in multiple
RDoC domains, specifically Positive Valence Systems, Cognitive Systems, and Sensorimotor Systems. In
Late-Life Depression (LLD), dysfunction in all these systems is common, portends poor outcomes, and
manifests as deficits in motivation and effort, executive dysfunction, and gait impairment. While studies of
dopamine function in early and midlife depression primarily focus on reward processing, they often exclude the
cognitive and sensorimotor domains relevant for older adults despite a recognized decline in dopamine
function with normal aging. The objectives of this collaborative R01 proposal between Columbia
University/New York State Psychiatric Institute and Vanderbilt University Medical Center are to: 1) characterize
dopaminergic dysfunction in LLD across multiple RDoC domains (Positive Valence Systems, Cognitive
Systems, and Sensorimotor Systems) at several levels of analysis (cellular [PET], circuit [MRI], and behavioral
/ self-report); and 2) examine the responsivity of dopamine-related circuits and behavior to stimulation with
levodopa (L-DOPA). Supported by pilot data, this project builds on our past work demonstrating that
dopamine function declines with aging, that dopaminergic dysfunction contributes to deficits in behavioral
measures of the Positive Valence Systems, Cognitive Systems, and Sensorimotor Systems, and that L-DOPA
administration improves performance in these systems. The long-term goal of this line of research is to
determine how dopaminergic dysfunction contributes to clinical presentations of LLD, how responsive
behavioral symptoms are to modulation of dopamine function, and to identify novel targets for future
interventions. Our approach is to enroll 60 psychiatrically healthy elders (30 per site) and 120 depressed
elders (60 per site) exhibiting likely dopaminergic dysfunction, characterized as either slowed processing
speed or slowed gait speed. Participants will undergo thorough clinical characterization and complete PET
imaging measuring dopamine synthesis and dopamine receptor availability, neuromelanin-sensitive MRI
measurement of long-term nigrostriatal dopamine transmission, task positive MRI focused on effort-based
decision making and reward processing, a comprehensive neurocognitive evaluation, a physical performance
evaluation, and measurement of inflammatory markers. To assess responsivity of the dopamine system to
modulation, depressed subjects then will be randomized to L-DOPA or placebo for 3 weeks, followed by repeat
multimodal MRI and cognitive/behavioral assessments. Using a cross-over design, participants will receive the
opposite intervention for an additional 3 weeks followed by clinical and cognitive assessments only. This
proposal is significant and innovative, as no prior published study has comprehensively examined
dopamine-dependent behaviors in LLD. This will inform treatment approaches focusing on facilitating cognition
and movement, reducing the effort cost of voluntary behavior, and promoting behavioral activation.

Public health relevance
PROJECT NARRATIVE Depression in older adults is characterized by poor motivation, cognitive deficits, and mobility impairment. Dopamine is a key neurochemical basis underlying all of these processes, but its precise contributions to the deficits seen in late-life depression are poorly understood. This study will comprehensively characterize dopaminergic dysfunction in Late-Life Depression and determine the degree to which it responds to pharmacologic modulation with levodopa.